Cancer Center Administration

PROJECT SUMMARY – ADMINISTRATIVE CORE
Successful cancer centers, whether free-standing or matrix, share traits that facilitate and ultimately lead to
increased quantity and quality of cancer care/research. Key among those traits is reliable infrastructure.
Infrastructure of quality services starts with effective administration. UWCCC Administration oversees 29 FTEs
who do the following: support management of multiple and complex sponsored research awards (pre and post);
provide fiscal oversight; govern information systems and informatics; direct development and marketing efforts;
direct multidisciplinary translational research administration; coordinate training and public/professional
education initiatives; manage facilities; execute UWCCC’s Strategic Operating Plan; provide human resources;
and continuously improve the organizational structure necessary to accomplish the center’s educational and
research missions. UWCCC encompasses 198 core members, >260 staff FTEs, a $27M annual overall budget,
and a $2.9M annual administrative budget.
UWCCC’s administrative infrastructure achieved the following: new inaugural budget process; new inaugural
membership and space committees; successful restructuring of clinical research operations; key external
recruitments of Assistant Directors in Population Sciences and Informatics; rebuilding of UWCCC informatics
infrastructure; new UWCCC Strategic Operating Plan; appointment of a new CCSG Research Administrator role;
implementation of shared resource fiscal tools; implementation of improved pilot process; established new
clinical trial contract and finance office; and executed key translational research initiatives with a new Precision
Medicine Molecular Tumor Board and Drug Discovery Consultation Panel.